Conformational rearrangements underlying ASIC1a gating

DESCRIPTION (provided by applicant): The epithelial sodium channel/degenerin (ENaC/Deg) family of ion channels is constituted of proteins that are implicated in mechanosensation, pain sensation, regulation of extracellular fluid volume and airway surface liquid volume. ENaC/Deg channels are gated by diverse stimuli including neuropeptides, mechanical forces, extracellular protons, and some of them are constitutively active, such as ENaCs. These channels are likely organized as homo- or hetero- trimers and are composed of subunits that have a similar topology with two transmembrane domains (TMs) connected by a large extracellular domain with short intracellular N- and C- termini. The first high resolution structure of the extracellular and membrane-spanning domains of an ENaC/Deg channel, Gallus gallus (chicken) acid-sensing ion channel 1 (cASIC1), was recently reported. ASICs are proton-gated channels expressed throughout neurons of mammalian central and peripheral nervous systems that exist in a resting, functionally inactive state, but undergo a rapid activation and desensitization following extracellular acidification. cASIC1 has a chalice-like shape with a large extracellular domain protruding from the plane of the membrane. The extracellular region is organized in discrete subdomains named the palm, knuckle, 2-ball, finger and thumb. The transition between the TMs and extracellular domain constitute the wrist. While the crystal structure provides great molecular details of cASIC1 in the desensitized state, the mechanism of gating of ASICs and other ENaC/Deg channels remains largely undefined. The first specific aim of this proposal will define conformational rearrangements in the wrist and pore of mouse ASIC1a associated with activation and desensitization. In the second specific aim we will address questions regarding the role of the thumb and palm subdomains in activation, desensitization and recovery from desensitization. Conformational changes that occur in restricted areas of the channel following extracellular acidification will be investigated by voltage clamp fluorometry, a technique that provides information regarding local protein motion associated with specific gating steps. The substituted- cysteine-accessibility method will be used to characterize the structure of specific regions in the closed and desensitized states. Studies proposed in this application address fundamental questions regarding the underlying mechanism of gating and desensitization of mouse ASIC1a. Information derived from this work will be valuable to comprehend the molecular mechanisms of regulation of Deg/ENaC channels.

Public health relevance
PUBLIC HEALTH RELEVANCE: The epithelial sodium channel/degenerin (ENaC/Deg) family of ion channels is constituted of proteins that are implicated in mechanosensation, pain sensation, regulation of extracellular fluid volume and airway surface liquid volume. These channels have evolved to sense a broad variety of stimuli with homologous structures. Information derived from this work will be valuable to comprehend the molecular mechanisms of regulation of these channels. The epithelial sodium channel/degenerin (ENaC/Deg) family of ion channels is constituted of proteins that are implicated in mechanosensation, pain sensation, regulation of extracellular fluid volume and airway surface liquid volume. These channels have evolved to sense a broad variety of stimuli with homologous structures. Information derived from this work will be valuable to comprehend the molecular mechanisms of regulation of these channels. __SpecificAimsTextDelimiter__ A. Specific aims The epithelial sodium channel/degenerin (ENaC/Deg) family of ion channels is constituted of proteins that are implicated in mechanosensation, pain sensation, regulation of extracellular fluid volume and airway surface liquid volume [1-4]. Malfunction and abnormal regulation of these channels can cause various pathological conditions including hypertension, hypotension and cystic-fibrosis like lung disease [3, 5-8]. ENaC/Deg channels are gated by diverse stimuli including neuropeptides, mechanical forces, extracellular protons, and some of them are constitutively active, such as ENaCs. These channels are likely organized as homo- or hetero-trimers and are composed of subunits that have a similar topology with two transmembrane domains connected by a large extracellular region and short intracellular N- and C- termini [9-12]. Acid-sensing ion channels (ASICs) are proton-gated channels expressed throughout neurons of the mammalian central and peripheral nervous systems. These channels remain in a resting, functionally inactive state, but undergo rapid activation and desensitization following extracellular acidification. The first high resolution structure of the extracellular and membrane-spanning domains of an ENaC/Deg channel, Gallus gallus (chicken) ASIC1 (cASIC1), was recently reported [13]. cASIC1 has a chalice-like shape with a large extracellular domain protruding from the plane of the membrane. The extracellular region is organized in discrete subdomains, and using the analogy of a hand have been named the "palm, knuckle, b-ball, finger and thumb" [13]. The transition between the transmembrane and extracellular domains constitute the wrist [13]. While the crystal structure provides molecular details of cASIC1 in the desensitized state, the mechanism of gating of ASICs and other ENaC/Deg channels remain largely undefined. Our preliminary data suggest that the palm, thumb, and region preceding the second transmembrane domain of mouse ASIC1a (mASIC1a) undergo conformational rearrangements following extracellular acidification. The central hypothesis of our proposal is that the wrist of ASIC1 couples proton-binding within the periphery of the extracellular domain to opening and closing of the channel's pore. Studies proposed in this application address fundamental questions regarding the underlying mechanism of gating and desensitization of mASIC1a. The present investigation seeks to extend our understanding of how ENaC/Deg channels are gated by extracellular factors. The specific aims of this proposal are: Specific Aim 1. To define conformational rearrangements in the wrist and pore of mASIC1a associated with activation and desensitization Hypothesis: The wrist communicates conformational changes initiated in the proton-binding site(s) to the pore of mASIC1a Rationale: The pore of cASIC1 in the desensitized state is defined by residues in the second transmembrane domain, although a segment of the outer vestibule is formed by residues of the first transmembrane domain [13]. At the present it is unknown how conformational rearrangements initiated in the ectodomain of the channel by extracellular acidification are translated into opening and closing of the channel's pore. Our studies suggest that proton-binding to the ectodomain induces a conformational change in the region preceding the second transmembrane domain that directly results in opening of the channel's pore [14]. In specific aim 1A we will define if the wrist provides functional coupling between the extracellular domain and the pore of mASIC1a. In specific aim 1B we will use the cysteine-substituted-accessibility method to determine whether desensitization involves a structural reorganization limited to the extracellular domain or if it engages rearrangements that extend into the pore of the channel. In specific aim 1C we will use the cysteine- substituted-accessibility method and site-directed mutagenesis to define structural requirements for opening of the pore of mASIC1a. Specific Aim 2. To define conformational rearrangements in the extracellular domain associated with activation and desensitization of mASIC1a Hypothesis: Conformational rearrangements in the palm and thumb subdomains initiated by extracellular acidification are directly translated into activation and desensitization of mASIC1a. Rationale. The first and second transmembrane domains of cASIC1 are connected to b-strands 1 and 12 in the palm subdomain, respectively [13]. The region connecting the ectodomain with the transmembrane domains is in close proximity to the base of a cylindrical structure termed the thumb. Our preliminary data indicate that the thumb and palm domain undergo conformational rearrangements following extracellular acidification. Proposed studies will use voltage clamp fluorometry to characterize conformational rearrangements that occur during activation, desensitization, and recovery in the thumb and palm of mASIC1a. In Specific Aim 2A we will define the role of the thumb subdomain in activation and desensitization. In addition, we will use the cysteine-substituted-accessibility method to determine if the thumb subdomain has different conformations in the closed and desensitized states. In Specific Aim 2B we will use voltage clamp fluorometry to define whether conformational changes in the palm are associated with desensitization of the channel. Recovery reflects the transition of the channel from the desensitized to the resting state. Our preliminary studies suggest that the palm undergoes a conformational shift more rapidly than the thumb during recovery. In Specific Aim 2C we will examine whether recovery from desensitization requires sequential conformational rearrangements in the palm and base of the thumb.